Stress-induced tRNA-derived small RNAs in cardiac fibrosis

PROJECT ABSTRACT
Heart failure (HF) remains the leading cause of morbidity and mortality in the US, impacting approximately 6.2
million Americans. Cardiac fibrosis, resulting from disruptions in cardiac homeostasis and subsequent injury,
stands as a major contributor to the detrimental remodeling of the heart that ultimately leads to HF. Therefore,
identifying novel therapeutic pathways is crucial for advancing treatment options in the field. Recent studies have
shown that under stress conditions, tRNAs can be processed by ribonucleases into smaller regulatory fragments
known as tRNA-derived small RNAs (tDRs), which serve as an adaptive mechanism helping cells cope with
stressors. Emerging evidence indicated that tDRs play critical roles in cellular stress response machineries
during diverse biological processes. However, the regulatory functions of tDR in cardiac fibrosis remain largely
unexplored. To uncover functional tDRs that are crucial for fibrosis pathways, we utilized an optimized tDR
sequencing technique known as ARM-seq to profile the differentially regulated tDRs in cardiac fibroblasts (CFs)
during ischemic response. Initial functional screening of the five most significantly regulated tDRs identified a
potent anti-fibrotic tDR derived from the 3’-end of tRNA-Asp-GTC (Asp-GTC-3’tDR). Our pilot in vivo studies
demonstrate that delivering Asp-GTC-3’tDR mimics to the heart effectively reduces cardiac fibrosis and improves
cardiac functions in a mouse myocardial infarction model. Conversely, inhibition of this tDR using our optimal
locked-nucleic acid antisense promotes fibrotic responses in the heart. Mechanistically, our preliminary data
suggest that autophagy pathway, particularly ribophagy, plays a critical role in mediating the anti-fibrotic effects
of Asp-GTC-3’tDR. The primary objective of this project is to investigate the anti-fibrotic roles of Asp-GTC-3’tDR
in cardiac fibrosis, with the ultimate goal of developing novel tDR-based interventions for treating cardiac fibrosis.
By leveraging a comprehensive toolkit designed to study tDR functions, we aim to elucidate the functional roles
and regulatory mechanisms of Asp-GTC-3’tDR in both cell culture and mouse acute and chronic cardiac fibrosis
models using the complementary gain-of-function and loss-of-function approaches. This will be followed by the
development of innovative strategies for Asp-GTC-3’tDR expression, including the delivery of DNA analogs of
Asp-GTC-3’tDR or our engineered CRISPR/Cas13 machinery to the heart, as a means of treating cardiac fibrosis.
The successful completion of this study will define a new area of RNA biology within the context of cardiac
fibrosis and provide proof-of-concept for targeting Asp-GTC-3’tDR as a novel first-in-class treatment for cardiac
fibrosis.

Public health relevance
PROJECT NARRATIVE Stress to the heart tissue can lead to the development of scar tissue, accelerating the progression of poor heart function, the most common cause of heart-related hospitalizations and death worldwide. Our research has discovered a new class of RNA molecules (tDRs) that can delay or reverse heart tissue scar formation. The main goal of this proposal is to test how tDRs lead to scar formation, and whether they can be used to form the basis for new types of therapies that would ultimately decrease the burden of heart failure.